Extensible Open Source Zero-Footprint Web Viewer for Cancer Imaging Research

Project Summary/Abstract
The Open Health Imaging Foundation (OHIF) Viewer and its underlying libraries such as Cornerstone have
become the standard framework for web-based imaging informatics technologies in cancer research and
beyond, supporting hundreds of open-source projects with thousands of users. Through OHIF, developers can:
1) add new innovative tools as extensions to the OHIF Viewer; 2) use specific OHIF modules or libraries to
build their own custom tools; and 3) web-enable existing desktop informatics platforms. To support the
transition from desktop to web-based tools, researchers need well-supported frameworks to build upon.
Currently, many cancer research image viewers require software to be installed on each user's local
workstation, a drawback which limits accessibility and ease of collaboration. Most web-viewers available today
are either proprietary, closed systems, or open-source research applications that use legacy technologies. For
cancer imaging research that requires multi-site collaboration, there is a growing need for a framework that can
enable researchers to review images and collaborate with colleagues remotely. OHIF’s zero-footprint web-
viewer tools provide enormous usability benefits for end users, who gain instant access to view data across
computers without any software to install or update.
Under a prior NCI ITCR U24 grant, we developed the OHIF Framework, which provides a professional-
grade, free, open-source web-based imaging environment for cancer research with image review, annotation
functionality, and a user-friendly interface. The OHIF Viewer relies on standards, which has enabled easy
integration with other systems, and it can be extended to provide custom functionality without modifying the
core application. Additionally, its components can be re-used to rapidly develop new applications and help
enable the transition to cloud computing for cancer research tools.
The core goal of this proposal is to enhance and sustain the OHIF platform and broaden the user and
contributor base of this technology. The current project has three aims: 1) extend the web-viewer’s cancer
imaging visualization and analysis capabilities; 2) reduce barriers to adoption by creating ready-to-use
installers for on-premises and cloud-hosted deployment; and 3) expand our support infrastructure for the
cancer research community. For community support, we will enhance our outreach, engagement, and support
initiatives to foster collaboration with developers and end users. In order to facilitate clinical translation and
share our experience with regulatory compliance, we will implement a quality management system (QMS) for
core OHIF framework development and regularly release design documentation to the community.
Enhancing the platform's functionality, easing installation, and enriching support will allow researchers
to better collaborate to evaluate the nature of cancer disease progression and response to treatment. With the
widespread adoption of the OHIF platform to date, the impact of these improvements will be far reaching.

Public health relevance
Project Narrative The Open Health Imaging Foundation (OHIF) Viewer is a free, professional-grade, open source, web-based medical imaging viewer and application framework that our team has created for the cancer community. OHIF has been widely adopted by hundreds of imaging informatics projects in cancer research and beyond to visualize and quantify disease within patients’ imaging exams. The current proposal will enhance and sustain the platform to expand its image visualization and analysis capabilities, create user-friendly deployment methods, and provide developer, end user, and regulatory support to help researchers better evaluate the nature of cancer disease progression and response to treatment.